BASE IDIQ TITLE: TECHNICAL, PROGRAMMATIC AND OTHER SUPPORT SERVICES TO THE NCI CSSI.TASK ORDER TITLE: NCI OCCPR WEBSITE MAINTENANCE

The purpose of this task order is to provide website maintenance to CSSI, NCI Office of the Director, and other supporting NCI Divisions/Centers/Offices that align with the center’s mission. CSSI is seeking a contractor that will, acting independently and not as an agent of the Federal Government, provide these support services in the task area outlined below.